Investigator Development Core

INVESTIGATOR DEVELOPMENT CORE-ABSTRACT
The Investigator Development Core (IDC) will ensure that the NY Center for Minority Health, Equity and Social
Justice (NYC-MHESJ) addresses the development of underrepresented minority early-career investigators in
basic biomedical, behavioral, and clinical research through a pilot project program, mentoring, and other
professional development activities. The pilot project program will allow researchers to generate preliminary data
for grant applications, mainly focusing on research related to diseases that disproportionally impact minority or
other disparity populations or those that address health disparities. Additional IDC professional development
opportunities to increase junior faculty and post-doctoral fellows' participation, advancement, and leadership
capabilities will be linked to this core. The core goal is to enable our junior researchers to successfully apply for
extramural funding and progress in their academic careers. The specific aims of the core are to:
1) Develop and administer a pilot project program within the center focused on the academic development of
underrepresented minority junior faculty and post-docs across the full spectrum of research focused on addressing
health disparities.
2) Mentor the pilot project investigators for their career development, publications, and research outcomes
derived from pilot project funds.
3) Implement and facilitate a grant submission timeline for extramural funding appropriate to the pilot
investigator's career stage. The IDC is envisioned as a magnet and an engine - a magnet that attracts early-
stage investigators into health disparities research and an engine that nurtures them toward success in NIH grant
funding. Findings from the proposed pilot project health disparities research program will lead to new K, R, and
equivalent extramural grants, the outcomes of which will contribute to healthier communities across the nation.

Public health relevance
Per Funding Opportunity Announcement (FOA) Number RFA-MD-24-001 Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.